FAMU Center for Health Disparities Research

FAMU Center for Health Disparities Research
SUMMARY: The overarching goal of the Florida A&M University (FAMU) RCMI Center application (2024-2029) is
to continue the progress of an interdisciplinary Center addressing minority health and health disparities using the
previous achievements of the Center in reaching important milestones. Our Center for Health Disparities Research
will continue enhancing basic biomedical and behavioral research at FAMU while improving the investigator's
research skills. To achieve the goals of the Center, we are proposing the following Specific Aims: 1) Enhance
FAMU research capacity and rigor for basic biomedical/behavioral research pursuits by supporting innovative
research projects, expanding research infrastructure, and strengthening community engagement partnership and
activities that will create a sustainable research environment. Meanwhile, we will provide all investigators and core
leaders with the training and capacity to increase artificial intelligence (AI) use. This will lead to more accurate and
insightful scientific discoveries and better approaches to serving the communities.2) Increase the success rate of
FAMU investigators in obtaining extramural research funding by enabling investigators to develop innovative
research competencies through offering the Career Enhancement Program (CEP), innovative technology, and
research collaborations. 3) Support new faculty and early career investigators in health disparities research
by establishing an Investigator Development Core that will provide pilot project funding and a robust mentoring
program with a platform through the Career Enhancement Program. 4) Establish and support partnerships with
the community to create a sustainable research environment that addresses health disparities research by
establishing the RCMI Community Engagement Core (CEC) to promote early education awareness, detection, and
screening. Recruiting two senior investigators will significantly impact the Center's research efforts. One of
these recruited specializes in artificial intelligence (AI), and one specializes in cancer biology. The Center will also
support three Innovative research projects in basic biomedical and behavioral addressing mechanisms and
screening interventions to reduce health disparities among minorities. These research projects will address novel
therapy in breast cancer and pain therapy and investigate new approaches to promoting cervical cancer screening
among minorities. Achieving the goals of the Center will be significantly facilitated by the commitment and
partnership of the Mayo Clinic Comprehensive Cancer Center Jacksonville, Florida, with its Specialized
Programs of Research Excellence (SPORE) grants, which will provide an environment conducive to career
enhancement. The Center has an external independent evaluator to implement a formative and summative
evaluation plan to reach data-driven decisions. The funding of this RCMI Center will enable FAMU to continue to
achieve its mission of addressing health disparities by enhancing FAMU research capacity, increasing the number
of minority investigators, promoting minority health, and aiding in reducing minority health disparities.

Public health relevance
Public Health Impact: Florida A&M University proposes establishing the RCMI Center in collaboration and partnerships with community-based organizations to address minority health and health disparities research. The center will enhance FAMU’s research capacity, increase the number of minority research investigators, promote minority health, and aid in the reduction of health disparities.